Decorin mimetics for treating corneal scarring and neovascularization

PROJECT SUMMARY
The cornea is continuously subject to insults from the external environment that can lead to stromal
scarring and neovascularization, and, consequently, vision loss. Although corneal opacity is a leading cause of
sight impairment worldwide, there are limited treatments available for preventing corneal scarring and
angiogenesis after corneal injuries. Ultimately, loss of transparency is treated by corneal transplantation;
however, corneal angiogenesis in the host cornea is a major risk factor for corneal rejection. Therefore, there is
an urgent medical need for alternative treatment options.
Decorin is a major ECM component in the cornea that has a central role in regulating collagen
fibrillogenesis, as well as, cell behavior via the direct interaction with growth factors and cell surface receptors.
Studies have shown that decorin antagonizes TGF-β1 signaling, a central regulatory cytokine in corneal wound
healing that promotes ECM deposition and scar tissue formation. Following corneal injury, increased TGF-β1
levels induce keratocyte transdifferentiation into myofibroblasts, and, subsequently, corneal fibrosis (scarring).
Moreover, decorin also regulates the physiological balance between pro-and anti-angiogenic factors in the
normal and injured cornea via binding to VEGFR2. Decorin binding to VEGFR2 inhibits VEGFA, the natural
ligand of VEGFR2, thereby suppressing VEGF signaling, and consequently inhibiting angiogenesis. Decorin
deficiency aggravates corneal vascularization, while decorin upregulation, via gene therapy using an adeno-
associated virus, successfully inhibits corneal neovascularization in vivo. Therefore, decorin holds great
pharmaceutical potential for treating corneal injuries to prevent corneal scarring and neovascularization. This
proposal aims to characterize binding interface of decorin:TGFβ1 and decorin:VEGFR2 to engineer novel
decorin based drugs that inhibit TGFβ1 (Aim 1) and VEGFR2 (Aim 2) with higher affinity than decorin.
Our central hypothesis is that by obtaining in depth mechanistic understanding of the molecular interactions
between decorin and its targets we can design decorin-based pharmaceuticals with increased ability to prevent
corneal scarring and angiogenesis compared to native decorin and without off-target effects. For such,
decorin:TGFβ and decorin:VEGFR2 complexes will be modeled using deep learning computational methods,
and decorin based drugs produced by mutagenesis to increase their affinity to TGFβ and VEGFR2. The efficacy
of the decorin based drugs for preventing corneal scar formation and pathological neovascularization
will be verified using in vitro (Aim 1 and 2) and in vivo assays (Aim 3).

Public health relevance
PROJECT NARRATIVE Stromal scarring and angiogenesis are leading causes of sight impairment worldwide, however, currently, there are limited treatments available. Decorin antagonizes TGF-β1 signaling, inhibiting fibrosis and scar tissue formation, and suppresses VEGFR2:VEGF signaling, inhibiting angiogenesis. This proposal aims to obtain in depth mechanistic understanding of the molecular interactions between decorin and its targets to generate new decorin based drugs that inhibit TGFβ (Specific Aim 1) and VEGFR2 (Specific Aim 2), and thereafter verify their efficacy to promote scarless corneal wound healing and inhibit pathological neovascularization in the murine and rabbit animal models (Specific Aim 3).